Northwestern University Clinical and Translational Science Institute (NUCATS)

Contact PD/PI: LLOYD-JONES, DONALD M NRSA-Training-001 (304) ABSTRACT: The health of children and adolescents is a critical determinant of our nation's health over the entire life course. Yet, research into child health lags behind that for adults. In part, this reflects historical, cultural and economic forces that tend to divert investigators into careers other than pediatric research. To address this concern, the Northwestern University Clinical and Translational Sciences Institute (NUCATS) chose the unique approach of specifically training young investigators to apply engineering solutions to problems in child health. Our overall goal is to generate a community of pediatricians, data scientists and engineers who collaborate across disciplines, using modern technology to improve the health of children and adolescents. The central focus of this continuing and highly successful effort is this Multidisciplinary Training Program in Child and Adolescent Health TL1, which has three specific aims. In Aim 1, we will train 10 postdoctoral fellows in basic science or pediatrics for two years, in a creative and multidisciplinary environment where investigators are equipped to apply innovative engineering approaches to problems in child and adolescent health. The fellows must have a mentor in both pediatrics and engineering. Presently, their projects range from computer-controlled delivery of general anesthesia or using nanotechnology to treat brain tumors, to applying machine learning to optimize discharge planning. This innovative research experience is complemented by mentoring from the TL1 leadership and from their postdoctoral-fellow peers; required foundational elements, which promote communication across traditionally disparate scientific disciplines; required selective components, assigned to individual fellows to optimize their training in pediatric clinical and translational science; and a menu of enrichment opportunities that are optional for each trainee. All of these components include both didactic and experiential approaches. In Aim 2, to expand the pipeline of engineers entering child and adolescent health research, we will provide 2, one-year positions (1 supported by the CTSA and 1 by institutional funds) for predoctoral engineers entering the last year of PhD training, especially those representing underrepresented minorities, as they complete their research and write their thesis. By including engineering trainees who are interested in CTS in the training activities available to our TL1 postdoctoral fellows, we intend to enhance their potential commitment to pediatric translational science. Finally, in Aim 3, we will provide a summer research experience at Northwestern for 4 students in clinical post-baccalaureate programs at a traditionally underrepresented-minority institution. Our experience to date suggests that, with our ongoing involvement after the summer experience, many of these students have been inspired to seek careers in translational research. Together, these aims outline a comprehensive and successful program to increase the number and quality of investigators applying innovative approaches to improving child and adolescent health. Page 1639 Project Summary/Abstract Contact PD/PI: LLOYD-JONES, DONALD M NRSA-Training-001 (304)

Public health relevance
PROJECT NARRATIVE This proposal describes a plan to continue a novel program through which we will develop a community of researchers to apply engineering solutions to problems in child health. We will train clinical and basic science postdoctoral fellows with a common curriculum, so that they learn to work together to translate new technical advances into approaches to patient care. To expand the pipeline of trainees entering this field, we will also implement programs to attract predoctoral students and underrepresented-minority, masters-program students to child-health research.